Nucleophosmin Centered Diagnostics and Treatment of Ischemic Acute Kidney Injury

Project Summary/Abstract
We discovered that NPM1, a required Bax chaperone, promotes regulated cell death and acute kidney injury
(AKI) in the ischemic human kidney. The structure-function relationships (SAR) of NPM1 and its site of interaction
with Bax are unknown, limiting the development of novel drugs to prevent NPM/Bax toxicity in kidney cells that
are vulnerable to ischemic injury. Our integrative, cross disciplinary strategy combines cell biology with structural
and medicinal chemistry to identify the features that render NPM toxic to kidney cells and localize the NPM
domain responsible for binding Bax. Using protein structural analysis with x-ray crystallography, photo-labeling
and cross-linking, we will optimize a novel Bax peptide for preventing and treating ischemic AKI in high risk
cardiac surgery patients. In three aims, we will: (1) Characterize NPM structural features that cause regulated
renal cell death; (2) Optimize drug design to inhibit NPM:Bax interaction, and (3) Select an effective therapeutic
to prevent NPM:Bax toxicity in vitro and AKI in vivo. Prior validation of NPM’s causal role in ischemic injury in
the human kidney and its conserved regulation during ischemic cell death across divergent species substantially
increase the likelihood of translating our novel therapeutics to the clinic. Our scientific team has the combined
expertise in regulated cell death, clinical and experimental AKI, peptide and assay design, x-ray crystallography,
and mass spectrometry to advance our mechanistic understanding of ischemic cell death during AKI, identify
targets and novel drugs for pre-clinical study, and potentially change the standard-of care for AKI patients.

Public health relevance
Project Narrative Ischemic acute kidney injury (AKI) is a common and often a life-threatening consequence of reduced kidney blood flow during cardiac surgery caused by NPM, a key protein that promotes regulated cell death and tissue injury in the human kidney. We will use an integrated approach to characterize the structure-function relationship (SAR) of human NPM and Bax to identify novel targets for drug interventions with non-toxic, injectable peptides. Our goal is to prevent and treat regulated cell death that causes AKI during cardiac surgery, an insult that resembles experimental ischemia-reperfusion injury in which NPM and Bax are lethal co- toxins.